GENETIC SUSCEPTIBILITY TO GRAVES'-LIKE HYPERTHYROIDISM IN MICE

DESCRIPTION (provided by applicant): Graves' hyperthyroidism is caused by thyroid stimulating autoantibodies (TSAb) to the thyrotropin receptor (TSHR). Some mouse strains are susceptible, and some are resistant, to developing hyperthyroidism induced by TSHR- adenovirus immunization. This difference permits analyzing the genetic susceptibility to hyperthyroidism in mice. Recombinant inbred (RI) mice are stable lines derived by repeated brother x sister matings of the progeny of two strains. Our studies in genotyped CXB and BXH RI strains revealed that induced TSHR antibodies and hyperthyroidism are influenced by different chromosomal loci. We will build on these findings as follows: 1. Genetic controlofthyroidbaseline parameters and responsiveness to stimulation : To obtain insight into the genetic susceptibility for these parameters, we will study RI mice derived from parental strains differing in serum T4 and Tg values by: Determining T4 and Tg levels at baseline and after TSH stimulation in BXH and BXD RI sets of mice. Performing linkage analysis to identify chromosomes and loci responsible for variability in T4, Tg and TSH. 2. TSHR antibodies as a measure of immunity to the TSHR . AXB/BXA and DXB RI mice, derived fromparental strains differing in TSHR antibody responses (A versus B6 and DBA/2 versus B6 for the two RI sets, respectively) will be immunized with TSHR-adenovirus to: Determine induced TSHR antibody levels measured as TSH binding inhibition, TSAb and ELISA. TSAb bioactivity will be compared using CHO cells expressing human and mouse TSHR. Identify by linkage analysis the chromosomes/loci associated with these traits. 3. Susceptibility to hyperthyroidism induced by thyroid stimulating antibodies (TSAb). We will perform the following studies: Immunize AXB/BXA and BXD sets of RI mice with TSHR-adenovirus. To overcome resistance to induced hyperthyroidism in BXD mice, we will deplete Treg before TSHR-adenovirus immunization. Determine chromosomes/loci influencing iantibody induced hyperthyroidism in AXB/BXA and BXD strains. Overall, these studies in mice will provide the basis for future studies refining genetic loci and provide insight into approaches for phenotypic stratification of Graves' patients in human genome wide array analyses

Public health relevance
PUBLIC HEALTH RELEVANCE: Graves' hyperthyroidism is caused by thyroid stimulating antibodies to the thyrotropin receptor (TSHR) that mimic stimulation by TSH. The disease is multigenic but genome wide scans in large patient groups fail to reveal common genes except for MHC. We will use an induced model of Graves' hyperthyroidism in genetically typed inbred mice to establish the genetic basis for the development of TSHR antibodies and elevated serum thyroxine with the goal of providing insight into subsetting Graves' patients for future human genome wide array analyses. PROJECT NARRATIVE Graves' hyperthyroidism is caused by thyroid stimulating antibodies to the thyrotropin receptor (TSHR) that mimic stimulation by TSH. The disease is multigenic but genome wide scans in large patient groups fail to reveal common genes except for MHC. We will use an induced model of Graves' hyperthyroidism in genetically typed inbred mice to establish the genetic basis for the development of TSHR antibodies and elevated serum thyroxine with the goal of providing insight into subsetting Graves' patients for future human genome wide array analyses. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Graves' hyperthyroidism, a common disease with a strong genetic component that primarily affects women, is caused by thyroid stimulating autoantibodies (TSAb) to the thyrotropin receptor (TSHR). Genome wide scans in large patient groups have revealed that Graves' disease is multigenic and no gene has been identified that is common to all studies except for MHC. Some mouse strains are susceptible and some are resistant to developing hyperthyroidism induced by immunization with TSHR-adenovirus. This strain difference permits analyzing the genetic susceptibility to Graves'-like hyperthyroidism in an animal model. Recombinant inbred (RI) mice are derived by brother x sister matings of the progeny of two strains for >20 generations to generate homozygous lines. RI strains CXB, BXH, AXB/BXA and BXD share B6 ("B") as one parent and have been genotyped. Our studies in two small RI sets (CXB and BXH) have revealed that induction of TSHR antibodies and hyperthyroidism are influenced independently by different chromosomal loci. We propose to build on these findings by studying additional groups of RI mice, including the very large BXD set, as follows:- 1. Genetic control of thyroid baseline parameters and responsiveness to stimulation: Basal thyroid hormone levels and thyroid susceptibility to hyperfunction vary among mouse strains. To obtain genetic insight into these parameters, we will study RI strains derived from parental strains with high vs low baseline T4 values (and the converse for Tg), BXH (B6 x C3H parents) and BXD (B6 x DBA/2 parents), respectively. Thus, we will:- • Determine T4 at baseline and T4 and Tg after TSH stimulation in BXH (13 strains) and BXD (74 strains) • Perform linkage analysis for each group of RI strains, alone and combined, to identify chromosomes and loci responsible for the variation in these traits. These data will provide a broad database (as well as linkage information) for baseline serum T4 and Tg levels and provide the first linkage data for TSH-induced changes in thyroid function in mice. 2. TSHR antibodies as a measure of immunity to the TSHR: In CXB and BXH RI strains, loci on chromosomes 17 (MHC region), X, 9 and 12 (immunoglobulin H chain V region) are associated with TSHR antibody induction. AXB/BXA mice (derived from low antibody responder versus high antibody responder parents) and BXD mice (low verus high mouse-TSHR-specific TSAb) will be immunized with TSHR-adenovirus to:- • Determine TSHR antibody levels measured as TSH binding inhibition (TBI), TSAb, and ELISA. • TSAb bioactivity will be compared using CHO cells expressing mouse vs human TSHR. • Linkage analysis will be performed to identify the chromosomes/loci associated with these traits. Combining the linkage data for 26 AXB/BXA strains and 74 BXD strains with information for CXB and BXH groups (13 strains each) will provide the increased statistical power to "hone in" on shared chromosomal loci, particularly in the MHC and immunoglobulin H chain V region. Our findings for mice may shed light on the nature and function of immune response genes that play a role in the development of TSHR antibodies in humans. 3. Susceptibility to hyperthyroidism induced by thyroid stimulating antibodies (TSAb): We will expand our genetic findings for CXB and BXH mice on TSAb induced hyperthyroidism in the following RI sets of mice:- • AXB/BXA mice (26 strains) immunized with TSHR-adenovirus. • Because resistance to induced hyperthyroidism in B6 mice is partially overcome by Treg depletion, BXD mice will be depleted of Treg before TSHR-adenovirus immunization. • Serum T4 linkage data will be pooled for AXB/BXA and BXD strains, as well as for CXB and BXH mice (data already available). The statistical power will be greatly enhanced by such large strain numbers and will facilitate identifying chromosomal loci linked to thyroid hyperfunction. Overall, our findings will provide insight for phenotypic stratification of Graves' patients in human genome wide array analyses.